Dissecting the neurobiological basis of social control over alcohol self-administration

SUMMARY
Alcohol Use Disorder (AUD) is a global public health issue for which more effective treatments are urgently
needed. While it is widely appreciated that social context is a powerful modulator of human alcohol self-
administration. this factor has been largely ignored in preclinical AUD research. The development of an alcohol
self-administration model which allows experimental control over social context and tight control over alcohol
self-administration stands to reveal new information about the neurobiological bases of AUD. Specifically, the
present proposal seeks to experimentally determine the nature of the interaction between social interaction and
self-administered alcohol (i.e., complimentary vs. substitute goods) using a simple-to-implement preclinical AUD
model that allows the study of social-context as a factor regulating alcohol drinking behavior. Further, we seek
to determine how this interaction is changed by the development of alcohol dependence, during which we
hypothesize alcohol reinforcement transitions from being a mainly-positive reinforcer to a mainly- negative
reinforcer. Additionally, we will determine how male and female rats differ in terms of social context control over
alcohol self-administration behavior. We also propose to study the inverse relationship of this interaction; how
alcohol self-administration, alcohol dependence, and biological sex shape the nature and quality of social
interaction. To begin to dissect the neurobiological basis of the interaction between social context and alcohol
self-administration behavior, we propose to combine several neurohistochemical techniques to determine the
brain regions which contain neurons strongly activated during alcohol-seeking behavior in social vs. non-social
contexts (i.e., express the immediate early gene cFos). Further, we seek to determine how this brain-wide activity
maps onto the neurocircuitry of the prototypical social neuropeptide, oxytocin (i.e., to co-detect neurons which
synthesize the oxytocin peptide and/or which express the oxytocin receptor). Finally, we propose to leverage a
combination of novel AAV technologies, optogenetics, and pharmacology, to test the functional relevance of
neurons of the brain oxytocin neurocircuitry to control alcohol self-administration behavior in social vs. non-social
contexts. This highly innovative research proposal is also highly feasible given the expertise and technologies
offered by this unique team of researchers. Successful completion of this research project is expected to have a
high impact and a sustained impact on preclinical AUD research in broad terms, by 1. providing a means to
systematically examine the neurobiology of AUD from the largely ignored perspective of social context, 2.
Identifying the neurobiological basis for the control of social context over alcohol consumption, and 3. Determine
a causal role for neurons of the brain oxytocin system in the modulation of alcohol consumption across social
vs. non-social contexts. Ultimately, by providing new information about the neurobiology of AUD, this project
stands to move the field toward the generation of novel candidate treatments for AUD which have the best
chance to successfully make the leap across the pre-clinical to clinical translational divide.

Public health relevance
NARRATIVE Alcohol use disorder (AUD) is the third leading cause of preventable death in the United States and negatively affects the quality of life of millions of people. Social context is widely recognized as a major factor controlling human alcohol drinking behavior but is largely overlooked in preclinical studies. We propose to validate a simple- to-implement preclinical model that captures the impact of social context on alcohol drinking, and that will allow us to dissect the neurobiological basis for this social-alcohol interaction, beginning with the role of the prototypical social neuropeptide, oxytocin.